Developmental Funds Core

DEVELOPMENTAL FUNDS: ABSTRACT

The University of Kansas Cancer Center (KUCC) requests Cancer Center Support Grant (CCSG) Developmental Funds to support pilot research projects, supplement new faculty recruitment packages, and support staff investigators to promote translational and clinical science research activities and help extend those research activities to a variety of populations. Funding pilot projects, recruiting new faculty, and supporting staff investigators will collectively enrich research endeavors towards strategic priorities, enhance the ability of KUCC to serve the Cancer Center’s catchment area, and importantly help mitigate the impact of cancer in our region as well as nationally. KUCC leadership believes that activities supported by CCSG Developmental Funds will enable KUCC to provide a rich environment to develop paradigm-changing therapeutics and interventions and thereby enable the funding of multi- and transdisciplinary team-based grants. These funds will allow us to focus the power of precision medicine, basic science inquiry, drug discovery and development, and behavioral interventions to decrease cancer incidence, morbidity, and mortality. Furthermore, Developmental Funds will help KUCC promote a Cancer Center culture that supports our highest priority of leveraging the collective state-of-the-art basic, clinical, translational and population research programs to understand cancer at a fundamental level and catalyze a comprehensive, multidisciplinary approach to improve patient outcomes. KUCC has demonstrated a successful track record in its investment of CCSG Developmental Funds and other KUCC-directed funding mechanisms since receiving NCI designation in 2012 and will continue to grow a strong return on investment from these funds.